Unraveling the Aggregation of TDP43 Fragments Associated with ALS and FTD: Insights into Protein Quality Control Mechanisms and Cellular Vulnerability

Project Summary
As life expectancy increases, so does the prevalence of Alzheimer’s disease (AD) and AD-related
dementias (ADRD), posing significant healthcare burdens. These conditions are linked to aggregates
of specific proteins or proteolytic fragments in central nervous system cells. For example, C-terminal
fragments (CTFs) of the TAR DNA-binding protein 43 (TDP43) are the primary components of protein
inclusions in amyotrophic lateral sclerosis (ALS) and frontotemporal dementia (FTD), and are also
associated with ADRD. These fragments are generated by increased protein cleavage or defects in
protein quality control (PQC) systems, such as the pathways involved in protein degradation. Despite
ongoing research, the processes that produce toxic protein fragments and the cellular mechanisms
that respond to them are not fully understood.
Our lab specializes in protein degradation through the ubiquitin-proteasome system (UPS),
particularly with respect to proteolytic fragments. We have studied multiple disease-linked CTFs of
TDP43 and found that their N-termini, determined by cleavage sites, influence their metabolism,
aggregation potential, and toxicity. Additionally, we have identified two distinct UPS pathways that
recognize specific features of these fragments and help protect cells from aggregation. This suggests
that a cell’s vulnerability to CTF aggregation depends on how the fragment is generated and the PQC
pathways active within the cell. In this project, we will investigate a third potential mechanism for
removing aggregation-prone fragments linked to neurodegeneration and assess the susceptibility of
different brain cell types to protein cleavage and aggregation. This research will deepen our
understanding of neurodegenerative diseases and provide opportunities for student involvement in
cutting-edge research at Texas Woman’s University.

Public health relevance
Project Narrative In neurodegenerative diseases, protein fragments form aggregates in the brain, but the mechanisms behind their formation, metabolism, and toxicity are not fully understood. This research will explore cellular protein quality control systems and assess which brain cells are most vulnerable to aggregation. The findings could help develop therapies to treat or prevent neurodegeneration in humans.